Projection Specific Modulation of Neural Activity with A Non-genetic Method

Project Summary In psychiatry and neurology, there are many debilitating disorders based on aberrant circuits for which we do not have adequate treatment methods. Recent developments in optogenetics and viral technology have demonstrated that modulating the neural activity of specific projections in the brain is capable of rescuing behavioral deficits, including those relevant to depression, autism and anxiety. However, this approach requires genetic modification of neurons via viral transduction, which introduces a significant barrier for clinical applications due to safety concerns. Also, the current projection-targeted neural modulation methods all use visible light, limiting both the light penetration depth and the number of independent channels neuroscientists can use for recording and modulating neural activity. Here, I would like to propose a non-genetic method for projection-specific modulation of neural activity in freely behaving mammals. This approach will use gold nanorods, a near-infrared (NIR) absorber and heat generation for neural modulations. Our preliminary results have demonstrated that gold nanorods are internalized by neuron soma or axon terminals, are transported retrograde/anterograde through neural axons and are sufficient to modulate neural activity under NIR light after axon transport in vitro. The aim of this work is to continue the development of this approach from in vitro to in vivo, which will be crucial for its future clinical translation. In Aim 1, I will determine the internalization and axon transport of gold nanorods in vivo by characterizing brain slices with fluorescence microscopy and electron microscopy. CLARITY will be used to visualize the nanoparticles in the whole projection. The in vivo toxicity of gold nanorods will also be studied. In Aim 2, I will determine the mechanism of photothermal modulation of neural activity by patching clamp, particularly the types of ions and ion channels involved during the modulation process. I will also verify the conductions for in vivo modulation of neural activity using fiber photometry. In Aim 3, I will examine the effectiveness of projection-specific modulation of rodent behaviors with our developed gold nanorod methods in model circuits related to reward and anxiety. The completion of the aims will result in the first non-genetic method for projection-targeted modulation of neural activity. This method will complement optogenetic neural modulation and calcium imaging with an orthogonal NIR channel and will present a better opportunity for clinical therapeutic applications due to its non- genetic and non-viral nature. The work will be accomplished under a team of advisory members consisting of a good balance of neuroscientists and nanomaterial experts: Dr. Karl Deisseroth, Dr. Sam Gambhir, Dr. Hongjie Dai, Dr. Fan Yang and Dr. Talia Lerner. After the completion of the project, I will become proficient in various in vivo techniques, such as optogenetics, fiber photometry, CLARITY and rodent behavior experiments.

Public health relevance
Project Narrative Recently, the development of optogenetics has demonstrated that modulating neural activity in specific projections is capable of rescuing several key behavior deficits in depression, autism and anxiety. However, this method requires gene modification and viral transduction, creating a major barrier for clinical translation. In this work, I propose a non-genetic method to achieve projection-specific neural modulations in freely behaving animals.